Multiplexed Protein Assays

DESCRIPTION (provided by applicant): Our aim is to develop a highly parallel assay technology for obtaining information on protein abundance. This would enable the generation of high-resolution maps of the proteome of complex tissues, and assist in the detection of protein interactions. The technology is designed for analyzing complex and dynamic biological systems, including regulatory and communication systems that operate at the cellular and multicellular level.

Public health relevance
PUBLIC HEALTH RELEVANCE: We are developing technology to build detailed maps of proteins in biological systems, to enable new insights into how complex biological systems work, and how this is altered in disease. This understanding can be translated into diagnostic and prognostic tests, preventative strategies, and therapeutics.